Angiogenic Therapy: Novel Approaches to Enhance Bone Regeneration in Aging - LOAD

SUMMARY
Alzheimer’s Disease (AD) is the most common form of dementia in the elderly and the vast majority of
patients are designated as non-genetically dependent Late-Onset AD (LOAD). Several studies have shown
increased risk of fracture with dementia owing in part to increases in falls. On the flip side, several clinical studies
have also demonstrated that a fracture history can increase the risk for dementia.
Historically, the most widely used mouse models relevant to AD have used transgenic approaches to induce
relevant pathologies in young mice. Unfortunately, transgenic overexpression animal models do not effectively
produce the heterogeneity observed clinically in LOAD patients and thus are not ideal for therapy development
or evaluation. Hence, the NIA-funded Model Organism Development and Evaluation for Late-onset AD
(MODEL-AD) Center is developing, characterizing, and distributing novel mouse models expressing humanized,
clinically relevant risk factors. One such mouse model is the aging LOAD mouse (hAbeta/APOE4/Trem2*R47H,
Jax #030670). Therefore, as a logical extension of our parent R01 (AG060621), in this AD Supplement, we
propose to examine the impact of fracture and our novel fracture therapies on neuroinflammation and the
associated cognitive decline in aging LOAD mice. Our parent R01 focuses on developing novel drug therapies
such as Sirt1 activator, SRT1720 and thrombopoietic agents to improve fracture healing outcomes in old mice.
We found that SRT1720 administered systemically, TPO delivered locally, and TPO mimetic peptides (TMP)
delivered systemically were able to improve bone healing.
Based on these observations, we hypothesize that fracture increases age-dependent neuroinflammation
and cognitive decline in LOAD mice. We further hypothesize that treatment of aging fractured or unfractured
LOAD mice with SRT1720 or TMP will reduce neuroinflammation and slow cognitive decline. One Aim is
proposed in this Supplement. Aim 1. Determine the effects of a femoral fracture and treatment of femoral
fractures with SRT1720 or TMP on neuroinflammation and cognitive decline in aging LOAD mice. To
accomplish this aging LOAD mice will undergo baseline cognitive testing. Half of the mice will serve as uninjured
controls and half of the mice will undergo a surgically induced femoral fracture. Mice will be treated with
SRT1720, TMP, or vehicle control beginning at the time of surgery until mice are euthanized 6 months post-
surgery. Fracture healing, cognitive decline, neuroinflammation, the integrity of the Blood Brain Barrier (BBB)
will be assessed.
Successful completion of this Supplement will determine whether fracture results in more rapid cognitive
decline in a novel LOAD mouse model recently developed and characterized by the MODEL-AD consortium.
Importantly these studies may demonstrate that treatment with novel bone healing therapies SRT1720 and/or
TMP, which are known to improve fracture healing, may have the added benefit of slowing the cognitive decline
associated with LOAD.

Public health relevance
PROJECT NARRARIVE While it is well established that dementia patients have an increased risk of sustaining fractures, it is less well known that individuals sustaining fractures, especially hip fractures, have a higher risk of developing dementia than similarly aged individuals that did not sustain a fracture. Here we will use a mouse model of Alzheimer’s Disease to determine whether fracture increases cognitive impairment associated with Alzheimer’s Disease. We will also determine whether novel bone healing therapies may decrease the cognitive impairment associated with Alzheimer’s Disease.